OPTIMIZATION OF LYSPRO INSULIN IN ANALOG IN TYPE I DIABETES

The primary objective of this study is to characterize the optimal dosing regimen of Lispro insulin analog in Type I diabetic patients administered either alone or in combination with regular human insulin preparations.